Spectroscopy of Fe-S Cluster Proteins -- Information for Structure and Function

GM65440 Renewal Resubmission Project Summary
The element iron plays an enormous role in biology, including electron transport reactions
(ferredoxins), oxygen transport and storage (hemoglobin and myoglobin), catalysis
(nitrogenase, P-450, hydrogenase, and thousands of other enzymes), small molecule sensing
(especially O2, CO, and NO), and DNA processing and repair. The health-relatedness of a better
understanding of the structure and function of biological Fe is clear.
The general theme of research in the Cramer lab involves the use spectroscopy as a tool for
characterization of metals in biological systems. Much of this work involves the application of
synchrotron radiation x-ray sources. Thanks to enormous improvements of these sources,
experiments with exquisite sensitivity can now be conducted on dilute Fe samples. This includes
the technique Nuclear Resonance Vibrational Spectroscopy (NRVS), which is sensitive to the
motion of 57Fe in a sample. The x-ray experiments at international facilities are complemented
by IR and Raman measurements at the home lab.
One particular home-based experiment will involve pump-probe spectroscopy of sample in
cryosolvents at temperatures down to -100°C. A Nd:YAG OPO combination will be used to pump
the sample (initiate photochemistry) and a quantum cascade laser (QCL) or FT-IR will be used
to probe the subsequent reaction products.
The goals for the next 4 years can be divided into 2 major themes:
· better understanding of the catalytic intermediates of the enzymes that process hydrogen –
[NiFe] and [FeFe] hydrogenases, and
· information about structural changes that occur when Fe-S cluster proteins sense their
environment, including mitoNEET and NAF-1, two health-related proteins which sense and
communicate pH and redox status.
The overall vision of this research program is to use spectroscopic methods to better
understand how iron is used in important proteins, in ways that complement the information
that can be gathered from diffraction and microscopy. In the course of research on specific
topics, spectroscopic techniques will be further developed for the bioinorganic community.

Public health relevance
Project Narrative – 2023 Equipment Supplement The element iron plays an enormous role in biology, and we plan to study how iron contributes to catalysis (in hydrogenases) and to pH and small molecule sensing (in NEET proteins). Using very bright x-ray beams from synchrotron radiation sources, and bright infrared beams from NdYAG and quantum cascade lasers, we will study the vibrations of iron in the above systems, and this will provide structural information about how these proteins work. Information and insights gained from this project will help us better understand the biological chemistry of iron, so that we can learn from Nature to create a more efficient and healthier society and perhaps alleviate the damage from cancer and other diseases that occurs when some of these enzymes fail.